Data Management Core

CORE 2: DATA MANAGEMENTAND STATISTICAL CORE
ABSTRACT/SUMMARY
The Émergents ICEMR is sustained by a data-driven program, and the primary responsibility of the Data
Management & Statistical Epidemiology (DSME) Core will be to provide a central source of expertise related to
data management, biostatistical analyses, and coordination of secure data exchange and archiving across all
Core Components and Research Program Projects. The management of the data requires the establishment of
a pipeline for data flow to/from the core components and research projects, domestic and international partners
at different institutions. To meet this need, the DMSE will implement and coordinate the following: (a) provide
administrative support for data management and biostatistical analyses to ensure the success of the
Émergents ICEMR; (b) expand and maintain an integrated data management and storage system that
integrates clinical/sample data from research activities; and (c) develop and support ongoing
implementation of standard operating procedures (SOPs) regarding data security and participant
confidentiality. Dr. Ryan, will be the CORE 2: DMSE lead, supported by Dr. Ify Aniebo (ACEGID) and Dr.
Emmanuel Elanga (CRID). Dr. Ryan is a medical geographer, broadly trained in quantitative ecological modeling,
spatial analyses, and eco-informatic approaches to disease ecology. Dr Ryan has extensive experience as the
Data Management Core lead for large consortia research programmes both in the US and with international
partners. Throughout the ICEMR the DSME will (a) develop and support implementation of all standard operating
procedures (SOPs) related to data collection, security, management, and analyses across all projects; (b)
support quantitative study design and analytical results within all project proposals, which will be facilitated by
frequent and close communication with ongoing data collection, management, updating, and dissemination to
collaborators; (c) coordinate efficient and consistent utilization of data and statistical resources across the
projects by providing standard methodology and expert staff support that are readily accessible to all
investigators; (d) produce well curated and documented raw, archived, and public product data, and will ensure
metadata standards are met and maintained for a variety of outlets and repositories (e.g., Genbank, Data Dryad,
OSM, FGDL); (e) establish a central, secure integrated data management and storage system; (f) establish a
program-specific geoportal; and (g) maintain ongoing development of source code available through a Github
public repository, to release analytic code in a commented, sustainable release.

Public health relevance
CORE 2: DATA MANAGEMENTAND STATISTICAL CORE PROJECT NARRATIVE Developing and maintaining rigorous data quality and management systems throughout the cycle of any research program is paramount to safeguard data privacy and confidential standards, as well as to ensure the completeness, consistency, and validity of results generated. The Émergents ICEMR Data Management & Statistical Epidemiology (DSME) Core will provide a central source of expertise related to data management, biostatistical analyses, and coordination of secure data exchange and archiving across all Core Components and Research Program Projects. Primary responsibilities of the Core will be to, (a) develop and support implementation of all standard operating procedures (SOPs) related to data collection, security, management, and analyses; (b) support quantitative study design and analytical results (c) coordinate efficient and consistent utilization of data and statistical resources across the projects by providing standard methodology and expert staff support that are readily accessible to all investigators; (d) establish a central, secure integrated data management and storage system; and (e) ensure that analytic methods used for data generated through the program are distributed in a commented, sustainable manner.